Generation and characterization of a Cre-Lox regulated transgenic zebrafish model of SBMA

Spinal and bulbar muscular atrophy (SBMA or Kennedy's disease) is a slowly progressive, X-linked
neuromuscular disease affecting men. It is caused by the expansion of a CAG repeat within the androgen
receptor (AR) gene, encoding a glutamine tract in the protein. With no cure or therapy, identifying potential
therapeutic interventions for this patient population is pressing. We aim to create a Cre-inducible, low cost, and
high-throughput model of SBMA using zebrafish. Discoveries made from zebrafish research are highly
translatable to humans since zebrafish are vertebrates with extensive structural homology to human
neuroanatomy and muscle physiology. More specifically for SBMA patients, zebrafish express an AR that is
highly homologous in structure and function to human AR. Cre-inducibility of the human AR transgene will enable
the production of founder lines that are able to express high levels of the toxic polyglutamine-expanded AR. We
hypothesize this will lead to robust motor dysfunction in larval zebrafish. These larval zebrafish modeling SBMA
will be amenable to quick (over 1-2 weeks) chemical and drug library screens, or genetic modification(s) to
identify modulators of motor function. Such assays could be set up within only a few days and at a very low cost
compared to such assays in rodent models. Moreover, tissue specific Cre zebrafish lines can be crossed with
these SBMA zebrafish in future studies to investigate the relative role of motor neurons verses skeletal muscle
in the onset and progression of SBMA pathogenesis. A better understanding of the relative roles of each of these
cell types in disease will support clinical trial design for SBMA patients. Further, because SBMA shares properties
with other neurodegenerative, neuromuscular, and polyglutamine diseases, therapeutic targets identified in the
SBMA zebrafish model may also be applicable to some of these other disorders.

Public health relevance
Generation and characterization of a Cre-Lox-regulated transgenic zebrafish model of SBMA We will create an inducible and high-throughput zebrafish model of the neuromuscular disease, spinal and bulbar muscular atrophy (SBMA). This system will speed up the process by which researchers screen and identify approaches for treating SBMA.